Adipocyte-Eosinophil Communication and Its Role in Regulation of Airway Function

PROJECT SUMMARY
The concurrent rise in the prevalence of asthma and obesity poses a significant burden on health care system.
Obesity accompanied by loss of insulin sensitivity and compensatory hyperinsulinemia drives severe
inflammation and is a defining feature of poorly controlled asthma endotype. While we recognize that obesity
exacerbates and promotes asthmatic inflammation, the precise immunological and metabolic mechanisms
governing interactions between adipose tissue and the airway remain poorly understood. This knowledge gap
presents a significant roadblock in the development of effective therapeutic strategies for obese asthma
patients. Our recent novel findings show that in lean mice, adipose tissue recruits eosinophils and undergoes
adipocyte beiging and lipolysis in response to airway allergic inflammation in models of asthma. This discovery
is of paramount importance as it demonstrates, rather surprisingly, that adipose tissue and its resident
eosinophils play essential roles in the systemic response to lung allergic reactions. Moreover, we found that in
obese mice, adipose eosinophils prevent obesity-induced airway hyperresponsiveness (AHR) by reducing
circulating insulin. Collectively, our innovative findings underscore the vital role of communication between
adipose tissue and eosinophils in regulating airway function and inflammation in lean and obese mice.
However, the phenotype and regulatory nature of eosinophils in fat tissue, and their role in allergic
inflammation with and without obesity, remain unresolved. Based on preliminary evidence, we propose the
following central hypothesis: adipose eosinophils mobilize in response to airway inflammation and regulate
airway function by influencing adipocyte function and systemic energy metabolism. We will test this hypothesis
with the following three Specific Aims: (1) To determine adipose tissue and systemic metabolic response to
lung inflammation in lean and obese mice; (2) To determine regulatory nature of adipose eosinophil subset and
impact of eosinophils on adipocyte responses during airway inflammation in lean and obese mice; (3) To
determine the impact of regulatory eosinophils within adipose tissue on obesity-related lung inflammation and
airway hyperresponsiveness (AHR). Completion of these aims will elucidate mechanisms underlying
bidirectional communication between lung and adipose tissue in obese and non-obese asthma. Furthermore,
this research stands as a pivotal milestone in the development of efficacious therapeutic interventions for
managing these interrelated comorbid conditions.

Public health relevance
PROJECT NARRATIVE The concurrent rise of asthma and obesity is a modern epidemic that poses a significant burden on our health care system, and obese asthma represents a more severe form of disease. Our novel findings indicate that adipose tissue eosinophils actively respond to and regulate airway inflammation and function via adipose control of systemic insulin sensitivity. This project will address a two-way communication between lung and adipose tissue in lean and obese models of asthma, which will significantly increase our understanding of mechanisms of obese asthma.